CT-Derived Functional Imaging for Predicting Disease Progression in COPD

PROJECT SUMMARY
Chronic obstructive pulmonary disease (COPD) is the third leading cause of death in the United States, imposing
a significant economic burden due to its high morbidity and mortality. The Global Initiative for Chronic Obstructive
Lung Disease (GOLD) criteria is a universally accepted disease severity staging score. However, GOLD score
is not a strong predictor for mortality or progression risk at early or pre-disease stages. Early intervention is
crucial for slowing COPD progression and improving quality of life. Therefore, there is a need to develop robust,
quantitative metrics for characterizing disease state and progression risk. Existing quantitative computer
tomography (CT) methods are based on analyzing variations in CT Hounsfield Units (HU) and have shown
moderate to strong correlation with disease state. However, HU values are known to be breathing-effort
dependent. As a result, quantitative CT methods require heuristic normalization schemes to adjust for varying
lung inflation levels and are known to lack reproducibility. We previously developed a robust class of CT-derived
ventilation (CTV) methods that calculate breathing-induced volume changes apparent on inhale/exhale CT (IE-
CT) image pairs, as a surrogate for ventilation. In addition to numerical stability, our CTV demonstrated a higher
correlation with nuclear medicine-based ventilation imaging than any other method in the literature. We recently
extended the CTV framework to calculate changes in blood mass apparent on IE-CT, as a surrogate for
pulmonary perfusion. Our novel CT-Perfusion (CTP), taken together with CTV, comprise our CT-derived
functional imaging (CTFI) methodology. CTFIis the first to mathematically describe changes in inhale/exhale HU
values in terms of ventilation and perfusion. This allows us to compute VQ (ventilation/perfusion) ratio imaging
that is inherently normalized to patient breathing effort. Thus, any early microvascular changes or VQ mismatch
associated with COPD disease severity can potentially be detected and quantified on IE-CT images. We
hypothesize that a CTFI-informed machine learning model has higher discriminative power in assessing survival
and disease progression than traditional methods such as FEV1, BODE index and other quantitative imaging
markers. To test this hypothesis, we will utilize data from the Genetic Epidemiology of COPD (COPDgene) study,
a multicenter observational study designed to identify genetic factors associated with COPD. We will adapt state-
of-the art unsupervised deep learning methods and fully leverage the rich COPDgene data set to train a lung
lobe segmentation model and automate the CTFI calculation pipeline. Next, we will develop and validate both
physics-based and deep learning-based CTFI VQ scoring methods. Finally, we will develop a machine learning
model which takes clinical information and patient CTFI lobar scores (ventilation, perfusion, & VQ) as input, and
quantifies disease severity, predicts 5-year survival, and predicts future exacerbation and progression risk. All
developed software and training data will be made publicly available to encourage further research in this field.

Public health relevance
PROJECT NARRATIVE The proposed research will first develop the automated image processing pipeline needed to convert inhale/exhale CT image pairs into perfusion, ventilation, and VQ functional information using state-of-the-art deep learning methods. We will employ the functional information to develop machine learning models for quantifying COPD severity and predicting 5-year survival. Unlike existing approaches, our novel CT-derived functional imaging VQ markers are robust to patient breathing effort, and therefore have the potential to better inform both clinical decision making and assessments of therapeutic efficacy.